Is ERBB4 a Driver of BRAF WT Melanomas?

Combining immune checkpoint inhibitors with BRAF and MEK inhibitors has enabled
significant improvements in treating metastatic skin cutaneous melanomas that possess
activating mutations in the BRAF gene (“BRAF mutant melanomas”). In contrast, actionable
and specific targets in metastatic cutaneous melanomas that contain the wild-type BRAF gene
(“BRAF WT melanomas”) have yet to be discovered, hindering the development of more
effective strategies for treating these tumors. Here we propose to address that knowledge gap
by validating a candidate target in BRAF WT melanomas and strategies for therapeutic
intervention. Published and preliminary data have led to the following hypothesis: ERBB4
mutations or elevated ERBB4 transcription increase signaling by ERBB4-EGFR or ERBB4-
ERBB2 heterodimers, resulting in increased PI3 kinase signaling, cooperation with NF1 or
RAS gene mutations, and increased proliferation of BRAF WT melanomas. We will test
aspects of this hypothesis with two specific aims: (1) Which ERBB4 mutants found in BRAF
WT melanomas cause increased proliferation of BRAF WT melanoma cell lines? (2) Is
EGFR, ERBB2, or the PI3K pathway required for proliferation of the ERBB4-dependent,
BRAF-WT melanoma cell lines? We estimate that the predicted outcome of these studies will
lead to effective strategies for treating approximately 30% of metastatic BRAF WT
melanomas, revolutionizing the care of patients that carry these aggressive skin cancers.

Public health relevance
Despite advances in treating many cancers, metastatic skin cutaneous melanomas that harbor a wild-type BRAF gene (“wild-type BRAF melanomas) remain very difficult to treat. Here we test the hypothesis that ERBB4 gain-of-function mutant proteins interact with the EGF receptor or HER2/Neu receptor to stimulate the PI3K pathway, which cooperates with the mutations in the RAS or NF1 genes to drive the proliferation of wild-type BRAF melanomas. Thus, we predict that the successful completion of the proposed research will lead to sorely needed improvements in treating a very aggressive cancer.